Understanding the role of Hsp70 phosphorylation in proteostasis

Project Summary
Hsp70 is vital molecular chaperone that folds a large proportion of the proteome. Research has primarily focused
on how Hsp70 function specificity arises through regulation of a) expression of Hsp70, b) isoform differences in
the Hsp70 protein family and c) the variety of co-chaperone proteins that bind to the Hsp70 molecule. Despite
the identification of several phosphorylation sites on both yeast and mammalian Hsp70 through global proteomic
screens, the biological function of most of these sites remains unknown.
All organisms must respond to fluctuations in external temperature to maintain viability. Cells cope with heat
shock by inducing both the cell integrity and heat shock response pathways. Our preliminary studies have
determined that the cell integrity and heat shock response pathways are more intertwined than previously
thought. Upon heat shock, yeast Hsp70 is rapidly phosphorylated at a single site and correspondingly mediates
the response of yeast to heat stress.
In this proposal, we will investigate the impact of this site on chaperone function in yeast. Particularly we will
study the role of Hsp70 phosphorylation on aspects of the heat shock response including the formation of both
reversible aggregates and stress granules. In addition, we will investigate the hypothesis that phosphorylation of
Ssa1 feedbacks into cell integrity signaling by supporting the activity of cell integrity kinases.
Understanding the regulation and interplay of Hsp70 phosphorylation in yeast will provide us with a
completely novel way to target chaperone activity. It may be possible to target specific oncoproteins through
alteration of Hsp70 phosphorylation status and specific Hsp70 phospho-species may have a higher susceptibility
to inhibitors. The scope of this work has broad implications for a variety of diseases associated with MAP kinase
signaling and molecular chaperone function, including many types of cancer and neurodegenerative illnesses.

Public health relevance
Project Narrative This study will allow us to understand how the function of a major regulatory protein (Hsp70) is controlled in by phosphorylation in response to heat shock. The scope of this work has broad implications for a variety of diseases associated with both cell signaling and molecular chaperone function, including many types of cancer.